Research Education Component

Abstract
Research into the causes, presentation, prevention and treatment of Alzheimer's disease and related
dementias (ADRD) increasingly demands a team-based multi-disciplinary approach that includes clinicians,
clinical and basic science researchers. The goal of the University of Washington Alzheimer's Disease
Research Center Research Education Component (UW ADRC REC) is to foster the development of a thriving,
innovative and diverse ADRD research community that is able to define the varied biological and mechanistic
drivers of ADRD. The UW ADRC REC will first provide a one year broad-based curriculum to REC Trainees,
including basic, translational and clinical research trainees, in order to establish a common understanding of
the clinical presentation of ADRD as they are ere encountered in the clinic and studied in the lab. Support for
the widespread use of teleconferencing at training sessions and UW ADRC meetings will provide access to
this dynamic clinical and research environment to ADRD investigators studying aging and ADRD in American
Native communities and populations. The UW ADRC REC will second provide support to REC Investigators
new to the UW ADRC or entering the ADRD research field for the first time in accessing and interacting with
the vast array of expertise, data and resources available within the UW ADRC ecosystem. This support is
explicitly targeted to include young investigators whose developing research programs will form the pipeline for
research utilizing resources and data generated by the UW ADRC in the future. Last, the UW ADRC REC will
seek to fill a critical gap in training and expertise in the use of publicly available ADRD-related `big data'
throughout the national ADRD research community. Through its partnership with Seattle-based Sage
Bionetworks, it will establish and support an annual two-day ADRD Open Neuroscience Workshop that will
help ADRD-focused trainees and investigators develop proficiency with publicly-available datasets, their origins
and structures, their user interfaces, and statistical and computational approaches to their use. These
workshops will be open to individuals at the UW ADRC and other ADRCs nationally. Through ongoing
collaborations Sage Bionetworks, it will further support the seeding and support of mentored Open
Neuroscience working groups focused on developing new research projects based on these data. This will
include the progressive use of integrated clinical, neuropsychometric, imaging and biomarker, genetic and
pathological data generated throughout the UW ADRC in these ADRD Open Neuroscience Workshops.